Mentoring in patient-oriented research on HIV prevention in the U.S. and Global South

ABSTRACT
This is a career mentoring award to support Dr. Matthews with protected time to create and deploy a
sustainable, structured approach to mentoring and to increase the number of trainees mentored. The PI, Lynn
Matthews, MD, MPH is an infectious disease trained clinician-scientist with research expertise developing and
testing HIV prevention strategies for men and women in the context of sexual health and reproductive goals.
Her mentoring portfolio focuses on groups who face barriers to becoming independent investigators in science
and medicine. Mentees will work alongside Dr. Matthews on newly proposed research in this K24 and ongoing
NIH-funded studies in the U.S. and sub-Saharan Africa.
Dr. Matthews proposes mentoring aims to (1) Provide mentorship in HIV prevention research to an estimated
15 investigators in the U.S. and abroad. Dr. Matthews seeks training in skills and tools to effectively mentor
and optimize mentorship and support for trainees conducting patient-oriented research. (2) Establish a
structured mentoring program to support mentees (phase 1) and mentors (phase 2) to be delivered within the
UAB CFAR and adapted for collaborative partners.
Dr. Matthews proposes novel research aims using new skills gleaned through training aims. The research will
be informed by the Health Equity Implementation Framework to (1) explore preliminary implementation
strategies for novel PrEP agents for people of reproductive potential in Alabama and Uganda. She proposes a
rapid analysis approach to analyze in-depth interviews and focus group discussions conducted with key
stakeholders and end-users (people of reproductive potential with potential for HIV exposure) across the two
sites. Surveys with providers, administrators, and other key stakeholders will assess feasibility and
acceptability with an emphasis on issues of equity of the implementation strategies raised in the qualitative
work to inform a future implementation trial. She will then select preliminary implementation strategies for a
future adaptive trial through a modified Delphi process. Dr. Matthews and the team will use these data and
information from the literature to design an adaptive trial for evaluating implementation strategies for novel
PrEP for people of reproductive potential in rural Uganda and Alabama.
This award will contribute to the growth of talented researchers, while advancing the science of HIV prevention
implementation in the U.S. and sub-Saharan Africa.

Public health relevance
NARRATIVE This is a career mentoring award to support the PI, Dr. Lynn Matthews, of the University of Alabama at Birmingham to mentor trainees engaged in patient-oriented HIV prevention research. New proposed research will identify best practices to implement novel HIV PrEP products for people of reproductive potential.